Mechanistic Insights and Therapeutic Potential of the Glutaredoxin (Grx) System in the Lens

Summary
The most common cause of vision loss among the elderly is cataract. Oxidative stress is well known to cause
cellular and tissue damage, resulting in age-associated ocular diseases, including cataract. Protein
glutathionylation, the reversible formation of a mixed-disulfide between glutathione and protein thiols, is one of
the major oxidative protein modifications in response to oxidative stress. The glutaredoxin (Grx) system repairs
protein thiols and maintains cellular redox balance. The Grx system has two isoforms, the cytosolic Grx1 (also
known as thioltransferase) and the mitochondrial Grx2. The purpose of this proposal is to study how Grx system
dysfunction may affect the lens redox signaling and its transparency. We hypothesize that Grx1/Grx2 double
deletion may increase the lens susceptibility to ultraviolet (UV) radiation and aging by inhibiting nuclear
factor erythroid 2-related factor 2 (Nrf2)-dependent antioxidant response. We also propose that Grx-
activating compounds could protect the lens from UV-induced cataract formation. To prove our
hypotheses, the following Specific Aims are proposed: 1) To identify the role of the Grx system in protecting the
lens from UV radiation and aging using the Grx1/Grx2 DKO mouse as a model. 2) To examine the crosstalk
between the Grx system and the Nrf2-antioxidant pathway. 3) To test if Grx activating compounds could protect
the lens from UV-induced cataract formation. Successful completion of these aims will introduce the Grx system
as a drug target and may lead to the development of Grx-activating compounds as a potential therapeutic for
cataract and other oxidative stress-associated eye diseases.

Public health relevance
Project Narrative Oxidative stress plays a crucial role in cataract formation, therefore understanding the antioxidant repair mechanism in the lens is essential for cataract prevention and treatment. By using an innovative double knockout model, we will study the mechanisms of how the glutaredoxin (Grx) system, a group of thiol-based antioxidant enzymes, preserves lens transparency. We will also develop new Grx-activating compounds and evaluate their efficacy as a potential pharmacological strategy against cataract.